Center for Advancing Sociodemographic and Economic Study of Alzheimer's Disease and Related Dementias (CeASES-ADRD)

The mission of the Center for Advancing Sociodemographic and Economic Study of Alzheimer’s Disease
and Related Dementias (CeASES‐ADRD) is to advance innovative social science ADRD research, to
increase knowledge and technical capability of social science researchers, to broaden and diversify the
set of researchers working in the field and, to disseminate resources and communicate findings for
impact. CeASES‐ADRD targeted research themes are social and economic burden of ADRD over the life
course, and national and international trends and projections of ADRD. Research addressing these
themes will fill key research gaps, tackle some of the most pressing and immediate challenges of ADRD,
and address multiple NIA Strategic Directions. CeASES‐ADRD builds a unique set of interrelated
programs hosted over 2.5 days each year for advancing research, building networks and reducing
barriers to social scientists engaging in innovative ADRD research. These include, Science of ADRD for
Social Scientists program, network meetings for scientific presentations, discussions and network
building, and methodological and technical workshops. It unites a core set of multidisciplinary
researchers with complementary research expertise in the thematic areas, methodological and technical
skill sets, and in the use of myriad population level, longitudinal data sets. In addition, these researchers
have strengths in leadership and mentorship to support and grow the next generation of ADRD social
science researchers. CeASES‐ADRD has a leadership structure that brings together researchers from
University of Southern California, University of Texas, Austin, and Stanford, who have NIH‐funded
research portfolios of social science ADRD research, are long‐time collaborators with experience leading
large centers and who have had success building networks and mentoring diverse scholars. CeASES‐
ADRD utilizes additional key resources available to it through USC Schaeffer Center including an external
affairs staff for communication and dissemination of findings, a research programming staff for
providing technical support and expertise, a data librarian for supporting use of its rich data holdings.
CeASES‐ADRD collaborating researchers include directors of multiple NIA‐funded Centers including a
Resource Center for Minority Aging Research, an Alzheimer’s Disease Research Center and a Roybal
Center in Health Policy Simulation for network building and driving innovative science.

Public health relevance
The mission of the Center for Advancing Sociodemographic and Economic Study of Alzheimer’s Disease and Related Dementias (CeASES‐ADRD) is to advance innovative social science ADRD research, to increase knowledge and technical capability of social science researchers, to broaden and diversify the set of researchers working in the field and, to disseminate resources and communicate findings for impact. CeASES‐ADRD targeted research themes are social and economic burden of ADRD over the life course, and national and international trends and projections of ADRD and were chosen to fill research gaps of some of the most pressing and immediate challenges of ADRD and to align with multiple NIA Strategic Directions. CeASES‐ADRD strengths include: (1) a multidisciplinary research team from University of Southern California, University of Texas, Austin, and Stanford; (2) the development of a unique set of interrelated programs hosted over 2.5 days each year including the Science of ADRD for Social Scientists program, ADRD research network meetings, and methodological and technical workshops; and (3) the uniting of key resources including USC Schaeffer Center’s external affairs staff for dissemination of findings, a research programming staff and data librarian for technical support and expertise, and multiple NIA‐funded Centers including a Resource Center for Minority Aging Research, an Alzheimer’s Disease Research Center and a Roybal Center in Health Policy Simulation for network building and driving innovative science.